Admin Core

ADMINISTRATIVE CORE PROJECT SUMMARY
The Administrative Core (Admin Core) of the Bradley COBRE Centre on Sleep and Circadian Rhythms in Child and Adolescent Mental Health will be based at the Emma Pendleton Bradley Hospital. This center of excellence aims to build a comprehensive and sustainable resource to support the growth of research in the sleep/circadian/pediatric mental health domains while providing mentorship of junior Project Leaders for research and for transitioning to independent scientific careers with external funding. The Admin Core serves as the primary organizational and administrative heart of the Center and its activities, facilitating all aims and components. The structure of the Core includes an Executive Leadership Team, a Local Guidance Group, and an External Advisory Committee, in addition to the Admin Core, a Pediatric Biopsychology Core, a Sleep and Circadian Methods Core, along with projects proposed by 4 outstanding young investigators. The Admin Core will (1) establish and maintain the leadership teams providing advisory and oversight roles; (2) develop and implement structured review of mentors and project leaders; (3) implement programs and activities for training, including a summer research assistant program, support for trainees and project leaders to attend the annual SLEEP conference, and an annual retreat colloquium; (4) manage the Pilot Project Program, which is funded through contributions from Bradley Hospital, Lifespan Corporation, and the Admin Core, including solicitation and selection of applications; (5) develop and implement a plan with the External Advisory Committee for structured evaluation of the Center. A major goal of the Center’s leadership is to work toward variety in its leaders and advisors, mentors, investigators, and research participants. The burden of psychiatric illnesses, behavioral disturbances, and neurodevelopmental disorders on children, adolescents, and their families is immense, and the sleep disruptions that travel with and may lead to such maladies exacerbate the challenges. Starting from it’s founding as the first pediatric psychiatric hospital in the United States, Bradley Hospital continues to provide world-class care for pediatric mental disorders in all their forms and has excellent clinicians, clinical scientists, and clinical services. This environment provides fertile ground for cultivating researchers who can work on connections to sleep and circadian rhythms. The promise of this COBRE Center as a preeminent center of biomedical research excellence is strong, and the most important, special, and notable aspect of this proposed center is the vulnerable young people whose health and wellbeing are at the heart of our work.